Project 3 Cerchietti

PROJECT 3: SUMMARY/ABSTRACT
This project focus in the biology of diffuse large B-cell lymphoma (DLBCL) in older individuals (i.e., patients 75
years or older). Based on findings in national cohorts from our group and others, DLBCL in older patients is
associated with comparatively worse outcomes even when accounting for treatment intensity and lymphoma
subtype. Our preliminary data suggest that intrinsic biological differences in DLBCL in older patients may account
for their poor response to chemoimmunotherapy. For example, we found that DLBCL in older patients associates
with higher proportion of activated B-cell-like (ABC) DLBCLs and higher number of inflammatory cells in the
lymphoma microenvironment. The reasons for these differences are not yet fully elucidated. Since aging, even
healthy aging, is associated with epigenetic alterations across tissues and epigenetics influences the physiology
and pathology of B cells, we hypothesize that some of the biological differences in DLBCL in older patients is
driven by epigenetic alterations of aging (EAA). In this project, we will determine whether EAA in B cells
predispose them to lymphomagenesis driven by MYD88 mutations, a frequent event in ABC-DLBCLs. Other
projects in this P01 are exploring the mechanisms by which MYD88 and other immune synapse mutations
activating the BCR pathway, modify the epigenetic landscape of B cells to drive lymphomagenesis. Using “fertile
soil” concept, we proposed that EAAs make B cells prone to malignant transformation by immune synapse
mutations. Concomitantly, we propose that EAA affecting immune and stromal cells that populate the
microenvironment are prone to acquire inflammatory phenotypes that contribute to lymphoma progression. Other
projects in this P01 are exploring the epigenetic mechanisms that allow B cells in physiological and pathological
contexts to receive proliferation and survival signals from immune microenvironment cells. We plan to test our
central hypothesis and accomplish the objective of this project by pursuing these specific aims to: (1) Elucidate
EAAs that reprogram GC B cells and enable the activity of ABC-DLBCL oncogenes; (2) Elucidate mechanisms
in the aging microenvironment that are permissive for lymphomagenesis; and (3) Develop therapeutic
approaches that target the aging phenotype. Thus, our project will provide the scientific rationale to design
biologically driven chemotherapy-free combinatorial treatments for older DLBCL patients. Overall, our project is
integral to the ideas explored in this P01 adding a biologically and clinically relevant perspective from the aging
standpoint, for what we anticipate will be an unprecedented understanding of the complex epigenetic
mechanisms that regulate the immune synapse in DLBCL patients.

Public health relevance
PROJECT NARRATIVE The purpose of our studies is to understand if a common type of aggressive lymphoma (diffuse large B-cell lymphoma) represents a biologically distinct entity when arises in elderly people. We will study epigenetic mechanisms associated with aging in favoring the activity of oncogenes and how this process may represent unique therapeutic vulnerabilities. If successful, these studies will launch the development of specific and likely low-toxicity treatments that could benefit elderly patients with incurable lymphomas.